Investigating Amino Acid Depletion in the Tumor Microenvironment as a Metabolic Immune Checkpoint

PROJECT SUMMARY/ABSTRACT
Activating a patient's immune system to target cancer cells has emerged as an effective therapeutic strategy.
However, many cancer subtypes, including epithelial malignancies such as pancreatic, breast, and colorectal
cancers still respond poorly to existing T-cell therapies. Why immune-based strategies have shown such poor
success in treating these common cancers is not known. In addition to characterizing the inhibitory checkpoints
that restrain T-cell activation, our laboratory previously demonstrated that activated T-cells depend on
extracellular glucose and amino acids to sustain their viability and effector function. Over the last several years,
we have been studying the metabolic properties of the multiple cell types present in the tumor
microenvironment. In addition to tumor cell consumption of glucose and free amino acids, we have found that
tumor-associated fibroblasts can deplete glutamine and other nonessential amino acids from the extracellular
space. In particular, the tumor and fibroblast-dependent depletion of glutamine and cystine (cysteine) makes it
difficult for cells in the tumor microenvironment to maintain protein translation and redox homeostasis. We
have uncovered multiple novel mechanisms by which tumor and stromal cells adapt to amino acid depletion,
including utilizing extracellular proteins as a source of amino acids through macropinocytosis, adaptive
alterations in translation, and activation of the transsulfuration pathway to maintain endogenous cysteine levels
and glutathione levels. Whether tumor-infiltrating immune cells can use any or all of these adaptations is
unknown. Our preliminary evidence suggest that T-cells are unable to maintain their viability and effector
function when depleted of either glutamine and/or cysteine. Therefore, we hypothesize that the tumor
microenvironment drives immunosuppression by depleting these non-essential amino acids. To address this
hypothesis, we propose three Specific Aims: 1) Study whether cancer-associated fibroblasts contribute to
immunosuppression by depleting extracellular free amino acids, 2) Determine the mechanism by which
glutamine depletion impairs anti-tumor immune function, and 3) Examine whether cysteine depletion in tumor-
infiltrating immune cells results in impaired mitochondrial redox homeostasis and/or reduced effector function.
Through these studies, we hope to demonstrate how depletion of glutamine and cysteine drives
immunosuppression within the tumor microenvironment and identify mechanisms by which these amino acids
can be restored to levels that will sustain an anti-tumor immune response.

Public health relevance
PROJECT NARRATIVE The extracellular environment within tumors is often depleted of nutrients required for immune cell proliferation and function. We have recently shown that while transformed cells and tumor- associated fibroblasts can catabolize alternative nutrient substrates to maintain intracellular amino acid pools, tumor-infiltrating T cells remain critically dependent on free amino acid availability. In human tumors, the most frequently depleted amino acids are those involved in sustaining critical cellular processes in addition to protein translation. Based on these observations, we will study whether the depletion of non-essential amino acids such as glutamine and cysteine alter the function of tumor-infiltrating immune cells and whether restoring these levels may enhance immune-based therapies in solid tumors.